Integrating Nonpharmacologic Strategies for Pain with Inclusion, Respect, and Equity (INSPIRE): Tailored digital tools, telehealth coaching, and primary care coordination

PROJECT SUMMARY/ABSTRACT
Chronic pain (CP) is one of the most common and debilitating medical conditions resulting in substantial
morbidity, lower quality of life and tremendous health care costs. With ongoing and tragic consequences,
opioids were overprescribed creating a surge in opioid use disorders and overdose deaths. Although non-
pharmacologic interventions have a strong evidence base, these interventions are rarely available and
expensive. The common co-morbidities of psychiatric and substance use disorders trigger further stigma and
lower quality care.
Subjective reports of pain symptoms and the cultural meanings ascribed to them create a situation ripe for
health care disparities driven by multilevel biases on individual, provider, and systemic levels. These biases
are manifested in stigmatizing language and the denial of interventions to reduce pain and alleviate suffering.
Multiple studies have shown that racial and ethnic minorities with CP are especially mistreated. It is essential to
accelerate the creation of hybrid CP management programs that improve access to treatments while
simultaneously addressing the stigma, bias, and mistrust that further harm and isolate patients with CP.
The INSPIRE CP intervention creates a hybrid blend of tailored cognitive-behavioral therapy, physical
therapy, mindfulness, and pain education delivered via a trilingual mobile app and supported by a telehealth
pain coach providing essential care coordination with PCPs within the EHR. PROs for pain, depression,
anxiety, substance use, and a range of social risks and needs will be regularly collected, summarized in the
coaching dashboard, and shared with PCPs. The intervention builds on an existing, in person pain program for
marginalized patients but significantly improves reach, expands cultural and linguistic adaptations, and directly
addresses multilevel bias and stigma through intensive community engagement, individual and group support,
and the provision of “tech tutoring” to improve digital health literacy.
The two year R61 development phase includes 3 specific aims with matched milestones: 1) creation of the
digital tool and coaching protocol using intensive community engagement, 2) iterative development of
educational and implementation strategies for health care staff and providers, and 3) a 3 month pilot test to
further assess acceptability and feasibility. The three year R33 validation phase includes 3 additional specific
aims 1) perform a pragmatic RCT with n=586 patients comparing INSPIRE to enhanced usual care, 2) analyze
secondary outcomes and the treatment effects model, and 3) a mixed method evaluation of implementation
outcomes using Normalization Process Theory to better design strategies for future scale.

Public health relevance
Project Narrative Despite strong evidence for integrative non-pharmacologic treatments for chronic pain, only 3% of patients have reliable access with minority and low-income populations affected more than others. Even when access is available, striking health care disparities exist often driven by provider biases and/or systemic or environmental barriers. The INSPIRE project creates an integrative, evidence-based digital system that delivers cognitive-behavioral therapy, physical therapy, mindfulness meditation, and personalized pain coaching using a smartphone app, telehealth visits, and primary care coordination using the electronic health record. Intervention features and trilingual materials will be collaboratively developed with the Black/African- American, Chinese, and Latinx communities then validated in a real world randomized trial.